Dendritic-Targeting Cortical Interneurons and Their Role in Associative Learning

PROJECT SUMMARY/ ABSTRACT GABA-containing Inhibitory interneurons are <20% of all cortical neurons, yet are critically important for proper cortical development and function. Dysfunction of inhibitory cortical interneurons is implicated in a wide range of mental and neurological disorders. Inhibitory interneurons comprise several subclasses which are distinguishable by their neurochemical content, morphology, electrophysiology and synaptic connectivity. A prominent subclass are somatostatin-containing interneurons, which preferentially target distal dendrites of excitatory neurons. What functions this distal inhibition performs in cortical computations, and how these interneurons contribute to sensation, perception and behavior, is still not fully understood. The PI has previously shown that somatostatin interneurons comprise (at least) two broad subsets which differ in their main axonal targets: those targeting most heavily layer 4, the layer receiving “bottom-up” sensory information, and those targeting layer 1, the layer receiving “top-down” contextual information from higher-order brain regions. The objective of the proposed research is to develop novel genetic approaches to target these distinct subsets and to shed light on their roles in cortical computations underlying behavior and learning. The proposed research will test the hypothesis that layer 4- and layer 1-targeting somatostatin interneurons have diverged to modulate and constrain the two major input systems of the cortex, and that during associative learning these two systems work in a push-pull fashion, to shift the balance between these two pathways in favor of top-down inputs. The proposed study will employ a novel combinatorial genetic approach with newly developed intersectional viral vectors, to separately target each of the two subsets for electrophysiological recording, two-photon calcium imaging and light-induced activation. Using these tools, the applicants will examine the detailed pattern of synaptic connections between these interneuron subsets and excitatory neurons, and will monitor changes in these two inhibitory systems as the animal learns to associate two stimuli. Achieving the aims of the proposal would be a major advance in our understanding of how cortical circuits are organized, how they evolved and how they are rewired during learning.

Public health relevance
PROJECT NARRATIVE The cerebral cortex is where sensory information becomes a conscious perception and where intentions are shaped into motor action plans. The cortex consists of diverse subsets of excitatory and inhibitory neurons with highly specific wiring schemes and with distinct roles in perception, behavior and cognition; any disruption to cortical neurons or circuits may lead to major neurological and mental disorders. The proposed project will significantly advance our understanding of the diverse subtypes of inhibitory cortical neurons and their role in rewiring the cortex during learning, understanding which could be used for future development of genetic and pharmacological strategies to combat mental and neurological diseases.